Role of the estrous cycle and nucleus accumbens signaling on incubation of oxycodone craving in female rats

Abstract
Mesolimbic regions, including the nucleus accumbens (NAc) mediate the motivational properties of
food, sex, and drug rewards, as well as cues that are paired with them. It is well established that
ovarian hormones influence motivation (Yoest et al., 2014) and potently regulate NAc function and
plasticity (Cyr et al., 2001; Le Saux et al., 2006; Peterson et al., 2015). In addition, glutamatergic
transmission in the NAc is essential for the initiation of motivated behaviors. The regulation of NAc
glutamatergic synaptic plasticity by ovarian hormones is proposed to underlie motivational responses
to food and drug rewards (Becker and Hu, 2008; Sinclair et al., 2017). However, the mechanisms
underlying the modulatory role of ovarian hormones on NAc function and motivation are poorly
understood. Thus, the goal of the proposed studies is to combine behavioral, biochemical and
electrophysiological approaches to understand how ovarian hormones influence motivation and NAc
function. These studies will not only provide a better understanding of the role of ovarian hormones in
motivation and NAc function, but they will also provide training and preparation for my independent
research career.

Public health relevance
PROJECT NARRATIVE: Food intake and feeding behaviors are regulated by the reproductive cycle. It has been shown that females have greater risk of suffering from obesity and eating disorders. In addition, females show enhanced behavioral responses to the rewarding properties of food and drugs of abuse compared to males. Furthermore, hormonal changes across the cycle can affect female responses to food, sex and addictive drugs. The goal of the proposed studies is to determine the role of the reproductive cycle and ovarian hormones in modulating cue-triggered motivation for food and the underlying neural mechanisms.